ASSESSING INHERITED MARKERS OF METABOLIC SYNDROME

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this study is to examine genetic risk factors associated with metabolic syndrome and related phenotypes in 500 otherwise healthy young adults (ages 18-35yrs) primarily within the minority population.